Investigating the extracellular RNA content of Staphylococcus aureus

PROJECT SUMMARY/ABSTRACT
Extracellular vesicles (EVs) are nano sized, membrane-enclosed vesicles produced and released by cells in all
domains of life. EVs contain a variety of biomolecules, such as lipids, proteins, and nucleic acids, and are
involved in a broad range of functions depending on the progenitor cell. The study of EVs in Gram-positive
bacteria is a relatively new field. Due to the architecture of the Gram-positive cell wall it was long thought to be
impossible for Gram-positive bacteria to produce EVs. However recent studies have shown EV production in a
variety of Gram-positive bacteria and implicated EVs in important functions like pathogenesis and immune
evasion. Staphylococcus aureus is both a commensal of humans and a highly dangerous bacterial pathogen.
EV production by S. aureus has been demonstrated and EVs shown to be cytolytic and play roles in immune
activation. Studies of S. aureus EV composition have focused on their protein content and to date there are no
reports describing the nucleic acid content of S. aureus EVs. S. aureus DNA and RNA are known to elicit an
immune response however the mechanism(s) through which these nucleic acids gain access to the host cell is
unknown. We hypothesize that EVs represent one mechanism through which S. aureus DNA/RNA is introduced
into host cells. In this exploratory proposal we present preliminary data showing that RNA is located inside and
associated with S. aureus EVs. We propose to identify the EV-associated RNA in EVs from five different S.
aureus strains by RNA-sequencing, and to use that information to define the S. aureus EV-RNome – i.e. the
RNA molecules found in EVs from all S. aureus strains. Defining the EV RNome will allow us to identify candidate
RNA molecules for future analysis to determine their contribution to the immune stimulating properties of EVs.

Public health relevance
PROJECT NARRATIVE Extracellular vesicles (EVs) are nano-sized, membrane-enclosed vesicles, released by Staphylococcus aureus, that are highly cytotoxic and can activate the host immune system. Preliminary data outlined in this proposal shows that S. aureus EVs contain RNA. We propose to identify the EV-associated RNA which we hypothesize plays a role in immune activation by EVs.